Rodent Phenotyping Core

PROJECT SUMMARY
The goal of the Rodent Phenotyping Core (RPC) is to increase the utility of mice and rats as
model organisms for vision research at The University of Iowa. The availability of a centralized
core for phenotyping will allow investigators to focus their resources on the science and
discoveries underlying vision research, rather than on training each lab’s personnel to perform
phenotyping. Such core-based services will yield more consistent and reproducible
phenotyping measures and in turn maximize the power of NEI-funded investigators to make
new discoveries.
The RPC will have the capability to perform detailed phenotyping of the anterior segment (slit-
lamp examination and photography, SD-OCT, gonioscopy, fluorescein angiography, and
intraocular pressure recording) and the posterior segment (fundus examination/photography,
electroretinogram, pupil light reflex, behavioral measurements of vision, acute suppression of
activity by light, and testing of optokinetic response).